PROTEIN TRAFFICKING IN LYMPHOCYTES

The orderly transport of proteins within the secretory pathway of eucaryotic cells is mediated by the specific recognition and fusion of transport vesicles with distinct target organelle-associated membrane proteins termed SNAREs. In our attempt to understand protein trafficking in lymphocytes, we have cloned novel SNAREs or SNARE- related proteins. Using the yeast two-hybrid system, we have isolated the cDNA for SNAP-23, a ubiquitously expressed membrane-associated protein involved in facilitating vesicle docking and fusion with the plasma membrane. We have also identified the novel kinase SNAK that phosphorylates SNAP-23 and regulates its association with syntaxin, another membrane trafficking protein. In addition, we have identified a novel syntaxin that localizes to late endosomes and are investigating the function of this protein in lymphocyte biology.We are also investigating the role of post-translational modifications in the transport of MHC class II molecules to antigen processing compartments. We have identified the phosphorylation sites on the MHC class II- associated invariant chain, have identifed protein kinase C as the kinase responsible for invariant chain phosphorylation, and are investigating the possibility that invariant chain phosphorylation enhances antigen presentation during the immune response. - antigen presentation, B lymphocytes, major histocompatibility complex class II, protein phosphorylation, protein transport,